Using Patient-Centered Guidelines in a Technology Platform to Improve Health Care in Adults with Sickle Cell Disease

The overall goal of this proposal is to prepare the principal investigator (PI) to become an independent
investigator with the career goal of developing health information technologies (Health IT) to improve disease-
specific knowledge in individuals with sickle cell disease (SCD). SCD is an inherited disorder of hemoglobin
that affects over 100,000 Americans, most of whom live in low-resourced neighborhoods. Acute SCD
complications result in 230,000 emergency department visits and $1.5 billion annually in acute-care
expenditures. Prior research indicates that increased disease-specific knowledge correlates with improved
clinical outcomes in SCD. Thus, targeting strategies to improve disease-specific knowledge is a high priority in
the care of individuals with SCD. Significant evidence describes how educational materials, including online
educational programs, can be used to increase disease-specific knowledge. In this proposal, the PI will
develop and evaluate a mobile phone technology intervention based on the prior evidence that technologies
can improve SCD-specific knowledge. The PI proposes a career development plan that includes a mentored
research experience with internationally recognized mentors with expertise in SCD, qualitative methods,
consumer health informatics, and user-centered design. The PI has done the following in preparation for this
application: (1) attended pediatric and adult hematology clinics at the Vanderbilt University Medical Center; (2)
partnered with the Sickle Cell Foundation of Tennessee and Sickle Cell Disease Association of America, our
local and national community based organizations to obtain input from adults with SCD about knowledge gaps
in their disease and to provide feedback about technology; (3) adapted 2014 NHLBI guidelines to be patient-
centered, understandable, and actionable based on input from the community; and (4) initiated a collaboration
with Cincinnati Children’s Hospital, developers of iManage, a mobile health application (mHealth app) designed
for individuals with SCD. The goal of this collaboration is incorporating the patient-centered version of the 2014
NHLBI guidelines into the app. The PI is a pediatric and internal medicine board certified physician and
biomedical informatician, with expertise in developing and evaluating Health IT applications across the life
span. This proposal describes a career development plan and research strategy in which the PI will gain new
and complementary skills, knowledge, and experience to become a leader in developing and evaluating Health
IT applications to be patient-centered and patient-driven to improve disease-specific knowledge in SCD. The
specific aims are to: (1) adapt iManage, an mHealth app with guidelines, for adults with SCD; and (2) evaluate
the adoption, usage, and usability of iManage, and (3) determine the improvement in disease-specific
knowledge in adults with SCD. Ultimately, the newly acquired skills developed in this mentored award will be
applied to the continuous process of ensuring that updated evidence-based strategies for SCD management
will be patient-driven, patient-centered, and accessible via current and future technologies for adults with SCD.

Public health relevance
Project Narrative Guidelines for evidence-based management of sickle cell disease (SCD) are available for health care providers in paper and electronic formats. However, no clinical science has been developed to make these guidelines patient-centered, accessible, and actionable for individuals with SCD. This proposal aims for the applicant to develop the clinical science skill sets for integrating clinical guidelines into a mobile health application for adults with SCD, and set the groundwork for the ongoing integration of new patient information with the use of current and new technologies for adults with SCD.